Reducing Variance in Diagnosis of Mental Disorders to Improve Patient Safety

Summary/Abstract:
Psychiatric diagnosis can be regarded as an inexact science due to a comparative absence of biomarkers and lab
tests for psychopathology as compared to physical health conditions. Nevertheless, accurate psychiatric
diagnosis is critical for patient safety, because misdiagnosis causes psychoactive medications to be
misprescribed, which results in substantial patient morbidity and mortality every year. More generally,
psychiatric diagnoses have been critiqued as themselves being constructs that are influenced by social,
political, and cultural histories. This has resulted in a general trend toward overdiagnosis of mental disorders
in a manner harmful to patients but beneficial to the manufacturers of pharmaceuticals
Reducing variance in psychiatric diagnostic practice is one step toward solving these problems. Without
consistency of diagnoses (i.e. precision in statistical terms), diagnostic accuracy cannot be achieved.
Consistency/precision also can aid the community to recognize inaccuracy in diagnosis better than it can be
recognized in a diagnostic context rife with variance. This proposed project seeks to reduce diagnostic variance
and thereby reduce diagnostic error and improve patient safety by achieving the following Specific Aims:
Aim 1. Assess the level of agreement across medical providers in their diagnostic processes and outputs for
mental disorders.
Aim 2. Determine the agreement between diagnostic practice by providers with (i) major diagnostic systems
published in psychiatry literature (e.g. DSM-5, ICD-10, HiTOP, dimensional systems) and (ii) non-diagnostic
systems that might still influence diagnostic practice (e.g. screening tools like PHQ-9, folk taxonomies for
mental disorders).
Aim 3. Disseminate diagnostic agreement and disagreement information back to study participants, who will
then self-evaluate patient cases from their own caseloads about whom they were more or less certain of their
original diagnosis.
Aim 4. Disseminate more generalizable information on diagnostic agreement based on a national sample of
physicians to the general scientific and medical communities.
The project will be conducted on site at two health system partners in Massachusetts and Washington state (50
physicians at each site), and in an additional nationally recruited sample of 150 physicians.

Public health relevance
Project Narrative: Reducing variance in psychiatric diagnostic practice is one step toward diagnostic accuracy, because without consistency (i.e. precision in statistical terms), accuracy cannot be achieved. We propose to reduce diagnostic variance for mental health and thereby improve patient safety at two health system partners and in a national sample of physicians. We will reduce diagnostic variance by measuring between-provider differences in diagnostic practice with a mixed-method research design, quantifying between-provider agreement and agreement of providers with published diagnostic systems, and providing direct feedback to partners about their own levels of diagnostic agreement and variance.